CRCNS: Neural Representations of Time Across Scales in Natural and Artificial Networks

PROJECT SUMMARY (See instructions):
This proposal works towards a deeper understanding of how the brain represents information across many
time scales using a combination of neurophysiological and computational approaches. State-of-the-art
recordings from non-human primates will track the flow of information across neurons and across time
scales in multiple brain regions. Computational data analyses will compare these results from predictions
of a theory for how the brain represents information across time scales. Computational work will study the
properties of artificial neural networks inspired by the theory and with properties of the observed
neurophysiological data.

Public health relevance
RELEVANCE (See instructions): The neural representation of time is implicated in several clinical conditions, including schizophrenia and memory disorders; a deeper understanding of how the brain represents the past could shed new light on this conditions. Moreover, deep artificial neural networks are used in many clinical applications. The new generation of deep networks developed in this project could lead to new applications, including sensory prosthetics for individuals with hearing impairments.